Bioinformatics CD-ROM Primer for High School Students

PERFORMANCE SITE(S) (organization, city, state) Red Hill Studios, Larkspur, CA KEY PERSONNEL. See instructions. Use continuation pages as neededto provide the required information in the format shown below. Start with Principal Investigator. List all other key personnel in alphabeticalorder, last name first. Name Organization Role on Project Hone, Robert Red Hill Studios PI Sanford, Walter Red Hill Studios Senior Producer McEvoy, Patrick Red Hill Studios Art Director Montano, Andreas Red Hill Studios Senior Programmer Rockman, Saul RockmanETAL Evaluation Consultant Brutlag, Douglas Stanford University Content Consultant Hilgert, Uwe Cold Spring Harbor Laboratory Content Consultant Dodge, Bernie San Diego State University Design Consultant Ward, VivianLee Access Excellence, National Health Educational Consultant Museum Disclosure Permission Statement. Applicable to SBIR/STTR Only. See instructions. El Yes Principal Investigator/Program Director (Last, first, middle): Hone, Robert W. RESEARCH GRANT